Vision Bioinformatics and Computation

VISION BIOINFORMATICS and COMPUTATION MODULE
Project Summary
The goal of the Vision Bioinformatics & Computation (VBC) module is to increase our
understanding of biological processes in vision research by applying state-of-the-art techniques,
specifically bioinformatics and custom programming, and by training the next generation of vision
researchers. Despite the University's excellent bioinformatics analysis and computational cores,
the lack of bioinformaticians/programmers with expertise in vision neuroscience and
ophthalmology prompted the creation of this module. Through VBC, NEI R01 investigators will
have easy access to high-level expertise in vision bioinformatics and custom programming as well
as the support needed to design, execute, analyze, interpret, and manage results required or
facilitated by informatics and computational applications. VBC enables NEI R01 investigators and
vision scientists to leverage “omics” data to accelerate
translational research and improve patient
care by providing access and training in cutting-edge functional genomics tools to identify novel
ocular disease genes and eye disease variants. VBC will also provide the expertise needed for
the development of customized acquisition and analysis pipelines for a wide variety of applications
including electrophysiology, visual function tests, and advanced imaging including multi-photon,
spinning disk, and confocal microscopy of both fixed and living tissue. These advancements are
critical to understanding disease mechanisms to facilitate early diagnostics and innovative new
approaches for clinical care.

Public health relevance
VISION BIOINFORMATICS and COMPUTATION MODULE Project Narrative The goal of the Vision Bioinformatics & Computation (VBC) module is to increase our understanding of biological processes in vision research by applying state-of-art techniques specifically bioinformatics and custom programming. Through VBC, NEI R01 investigators will have easy access to high-level expertise in vision bioinformatics and custom programming as well as the support needed to design, execute, analyze, interpret, and manage results required or facilitated by informatics and computational applications. VBC offers expertise to develop novel tools, software, and analytical pipelines for the integration, annotation, analysis, retrieval, and presentation of these data from basic and clinical studies of eye diseases.